Leadership and Operations Center (LOC), AIDS Clinical Trials Group (ACTG); LOC 1/

To more safely and efficiently treat COVID-19 participants, we request support to place COVID-19 Isolation PODS at 14 of the ACTG CRSs. The storage company, PODS, has developed stand-alone and CDC compliant units. Installation of a COVID-19 POD at CRS locations will primarily facilitate A5401 but also protocol A5395. These units additionally allow separation between these activities and our HIV patients for both COVID treatment and prevention studies. A5401 will study up to 10 different agents across phase 2 and phase 3 trials. This dedicated space will allow for efficient treatment of a high volume of study participants without comprising infection control measures of the general clinic population.

Public health relevance
The COVID19 pods will separate the HIV patients from the patients wishing to enroll in COVID 19 treatment and prevention clinical trials.